Development and commercialization of support tools to improve safety and efficiency of pharmacist-prescribed contraceptive services

Modified Project Summary/Abstract Section

Access to high efficacy contraceptive options and family planning services enable women to control the size and timing of their families which is paramount to allowing women to reach their full social, economic, and educational potential. In the US, more than 19 million women live in a county without reasonable access to the full range of contraceptive services, and 1.2 million of these women live in a county without a single health center offering the full range of services. Because 90% of the population lives within 5 miles of a pharmacy, pharmacist-prescribed contraceptive services (PPCSs) can dramatically decrease health disparities and combat the high unintended pregnancy rate in the US. In July 2023, the Food and Drug Administration (FDA) cleared Opill, the first over-the-counter progestin-only contraceptive. Currently, only 4% of oral contraceptive users take a progestin-only option. More patients will now turn to the pharmacy for contraceptive services, but pharmacies are not well-equipped to assist. To enable and modernize pharmacists prescribing, an Electronic Health Records (EHR) system must be utilized to increase safety, compliance, reimbursements, and scalability to meet the nation’s needs. The OvaryIt Pharmacy Platform (OPP) is a smart, contraceptive-specific EHR with embedded clinical decision support (CDS) tools to increase workflow efficiencies and assist providers in delivering safe, high-quality contraceptive care to patients. The OPP layers the CDC’s United States Medical Eligibility Criteria for Contraceptive Use (USMEC) guidelines with contraceptive prescribing best practices to create an end-to-end solution for prescribing contraceptives. The Phase I results demonstrate that the OPP has safety, efficiency, workload assessment, and usability benefits for pharmacists compared to the current standard paper charting workflow. The pharmacist participants in the Phase I study overwhelmingly preferred the OPP and indicated that it increases confidence and the feasibility of incorporating contraceptive services into their clinical workflows. The Specific Aims proposed in this application are designed to build upon the Phase I prototype lessons learned, to create a commercialized Software-as-a-Service (SaaS). The successful completion of this SBIR Phase II project is expected to result in the creation and commercialization of an end-user-driven SaaS platform that enables the adoption of pharmacist contraceptive services.

Public health relevance
Modified Public Health Relevance Section Pharmacist-prescribed contraceptive services have the potential to lower the rate of unplanned pregnancy in the US, however, several barriers must be addressed to enable widespread adoption. During Phase I, the OvaryIt Platform proved itself as a smart, contraceptive-specific electronic health record (EHR) system with embedded clinical decision support (CDS) tools to increase workflow efficiencies and assist pharmacists in delivering safe, high-quality contraceptive care to patients. The successful completion of this SBIR Phase II project is expected to result in the creation and commercialization of an end-user-driven SaaS platform that facilitates the adoption of pharmacist-prescribed contraceptive services.